Developing Modules to Address Microaggressions and Discriminatory Behaviors

Project Summary/Abstract
Background: Structural racism, defined as all the ways in which society cultivates racial discrimination through
reinforcing inequitable systems of education, healthcare, and employment, is manifested in macroaggressions,
which are contained within the policies and practices within institutions serving the biomedical sciences. These
macroaggressions foster and perpetuate discriminatory beliefs and practices that impair not only scientific
productivity and new discoveries in biomedical research but also the career trajectories of those from ethnic
minoritized groups and communities. Specifically, macroaggressions necessitate that individuals, especially
those in positions of power and leadership change their prejudices and actions. Thus, interventions for
macroaggressions and structural racism must recognize and address racial and ethnic prejudices and
discrimination that arise on an individual level, known as, racial microaggressions. The harm of racial
microaggressions is compounded when intersectional (relating to other marginalized backgrounds such as
gender, nativity status etc.) and thus creates overlapping systems of oppression. In order to create a culture
conducive to change within a range of biomedical research environments, trainees and their supervisors need
to better understand and acknowledge their own backgrounds and how their perspectives have been shaped
based upon a combination of their lived experiences interacting with a culture steeped in a history of structural
racism. In order to facilitate institutional-level change in policies and procedures that disproportionately impact
those from minoritized backgrounds, it is important that institutional leaders also be active change agents.
Purpose: The primary objective of the proposal is to create a series of self-directed, self-paced learning
modules that biomedical research trainees, supervisors, and organizational leaders can use to better
understand ways that structural racism influences their own biases and behaviors as well as strategies to use
when they are a target, bystander, or perpetrator of racial and intersectional microaggressions, and to use
these strategies in addressing institutional level policies indicative of racial and intersectional
macroaggressions. Additional objectives include collecting qualitative and quantitative data to evaluate the
feasibility, acceptability, accessibility, and initial impact of the new modules on a range of participants.
Methods and Design: A community-based participatory research (CBPR) approach will be used to ensure that
the new educational modules are based upon empirical science, are theoretically-grounded, and include
iterative feedback from a range of key stakeholder groups (e.g., biomedical trainees, supervisors, and leaders).
A preliminary evaluation including random assignment of participants to intervention and comparator conditions
will be used to determine whether the educational modules are associated with increases in knowledge and
self-efficacy in appropriately handling racial and intersectional macroaggressions and microaggressions.

Public health relevance
Project Narrative The proposed project will help address structural racism and discrimination, and its manifestations and impact on minoritized individuals and groups in the biomedical workforce by developing and utilizing a series of 16 training modules designed specifically for biomedical trainees, supervisors/faculty, and 4 briefer modules for institutional leaders. Using evidence-based methods, the training modules will be iteratively designed to be feasible, engaging, and efficient, as well as self-directed, self-paced, publicly accessible, and user-friendly in the context of one's workday. If successful the modules will provide participants with knowledge of and skills for dismantling the impacts of structural racism and discrimination on minoritized trainees' career development and enhance diversity, equity, and inclusion in the biomedical training environment, which aligns directly with the mission of the NIGMS' Division of Training, Workforce Development, and Diversity and NIH's UNITE initiative.